Clinical Protocol and Data Management

CLINICAL PROTOCOL AND DATA MANAGEMENT (CPDM)
PROJECT SUMMARY/ABSTRACT
Rutgers Cancer Institute had an unprecedented opportunity to expand clinical research to a
significant number of RWJBarnabas Health (RWJBH) system hospitals thanks to 1) Dr. Libutti’s
roles as Cancer Center Director and Senior VP for Oncology Services of RWJBH; 2) Dr.
Hochster’s roles as Cancer Center Associate Director for Clinical Research and Director of
Oncology Research for RWJBH; and 3) development of a system-wide academic health system
between Rutgers and RWJBH effective 01/01/2019 through a Master Affiliation Agreement.
Rutgers Cancer Institute’s Office of Human Research Services (OHRS) was established to meet
the current and future needs of Cancer Center Members and other stakeholders in the broader
university and hospital community. CPDM’s goal is to enable and enhance clinical and
translational research by providing centralized resources, information, and clinical research
expertise. All oncology research at all RWJBH hospitals and RU sites was consolidated under
OHRS’s direction and management with single PRMS oversight. Through comprehensive
planning, in conjunction with COE, intentional and strategic network growth brought clinical trials
to populations and geographic areas facing higher or otherwise significant cancer burden. In this
newly integrated and unified “one-site” model, CPDM has access to unprecedented numbers of
patients for clinical research activities to address catchment area priorities and needs. OHRS
serves as a centralized clinical research administration, housing all administrative tasks at
Rutgers Cancer Institute while providing oversight and direction for each clinical oncology
research operation site. OHRS has the responsibility of working with Rutgers and RWJBH clinical
investigators to manage the business, clinical and regulatory functions of all phases of cancer
clinical trials. The organizational structure comprises 196 FTEs with ten distinct offices based on
specialization within functional areas. OHRS activity increased along with the number of research
operation sites, clinical trials, and investigators. Following an “exceptional to outstanding” in the
last review, OHRS was enhanced by increased staff, full implementation of OnCore® clinical
research management system software, and systems for system-wide clinical trials. These
include global OnCore® access, use of eREG application for online DOAs access, and global use
of the Rutgers eIRB system for investigator registration and compliance. Screening, enrollment,
and available clinical trials increased significantly with the integration of RWJBH sites. Since the
last review, open treatment trials more than doubled and enrollment to therapeutic treatment trials
increased 80% with a 300% increase in enrollment from RWJBH sites.

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)